Predicting the neurophysiological consequences of pathogenic SCN2A variants

PROJECT SUMMARY/ABSTRACT
The SCN2A gene, which encodes a neuronal voltage-gated sodium channel, is a major genetic risk factor for a
wide range of neurodevelopmental disorders, including childhood epilepsies, autism spectrum disorder, and
intellectual disability. SCN2A channels are primarily expressed in axon initial segments and dendrites of
excitatory glutamatergic neurons, where they drive action potential initiation and backpropagation, respectively.
Pathogenic SCN2A mutations affecting protein structure and function modulate neuronal responses to synaptic
inputs leading to the cognitive and behavioral impairments and seizures observed in SCN2A-related disorders.
We discovered that the location of variants within the SCN2A protein is strong predictor of channel dysfunction,
accounting for approximately 40% of the variance in channel biophysical properties. However, the net effects of
complex and/or opposing channel biophysical properties on excitatory neuron excitability are difficult to predict
and the relationship between specific channel biophysical perturbations and resulting changes to neuronal
physiology is unclear. In this project, we propose to determine the consequences of 115 disease-associated
SCN2A mutations on channel biophysical properties and intrinsic physiological properties of neocortical
pyramidal neurons (Aim 1A). To do this, we will leverage in vitro whole-cell voltage-clamp recordings to build in
silico hidden Markov models of each SCN2A variant, which we will use to simulate heterozygous channel
dysfunction in a benchmarked mathematical model of a neocortical pyramidal neuron. Subsequently, we will use
interpretable machine learning algorithms to explain the relationship between functional perturbations and
neuronal physiology (Aim 1B). We also propose to validate neuronal simulations for 10 SCN2A mutations using
an experimental system called dynamic action potential clamp (Aim 2A). In this system, we will electrotonically
couple mammalian cells heterologously expressing SCN2A variants to a benchmarked model of an axon initial
segment and determine effects of heterozygous channel dysfunction on simulated neuronal excitability. Finally,
we aim to study 2 prototypical gain-of-function SCN2A mutations that heighten channel activity, potentiate
pyramidal neuron firing, and lead to seizures, and evaluate the feasibility of using dynamic action potential clamp
to test functional correction of abnormal neuronal excitability using specific sodium channel blockers (Aim 2B).
The long-term goal of this entire project is to computationally map and experimentally validate the relationships
among protein structure, channel dysfunction, neuronal physiology, and clinical phenotypes in SCN2A-related
disorders. Overall, our work will generate a granular genotype-phenotype relationship landscape of SCN2A-
related disorders revealing underlying molecular and cellular mechanisms of pathophysiology and will advance
a new approach methodology for testing precision medicine interventions for treating neurological disorders.

Public health relevance
PROJECT NARATIVE Mutations in the gene SCN2A, which gives rise to a protein in brain cells, have been implicated in a wide range of brain diseases, including epilepsy and autism. In this project, we will (1) determine the effects of 115 SCN2A mutations on protein function and brain cell activity using computational approaches, (2) validate the effect on brain cell activity for a subset of these mutations using an experimental system, and (3) assess the feasibility of using this system for testing the ability of drugs to correct abnormal brain cell activity. Our work will explain the impact on and relationship between abnormal protein function and brain cell activity in diseases caused by SCN2A mutations and will develop a drug testing system for evaluating therapies for each patient individually.